Division of Chemical Toxicology Symposia at the 266th National ACS Meeting

Project Summary/Abstract
The goal of this application is to obtain support for the American Chemical Society Division of Chemical
Toxicology (TOXI) at the 266th 2023 National Meeting program, which will be held August 13-17, 2023, in
San Francisco, CA. The mission of the Division of Chemical Toxicology is to improve human health and
public welfare by promoting the understanding of chemical mechanisms that govern disease processes and
the toxicity of drugs, environmental agents, and endogenous chemicals. Our goals include providing a
forum for communicating research in the field of chemical toxicology, encouraging research in chemical
mechanisms of toxicity, and facilitating connections between academia, industry, and policy in scientific
areas of mutual interest. We are also committed to developing the leadership and professional development
skills of scientists at all levels. Thus, the requested funds will be used to support travel awards and
expenses for graduate students, postdoctoral scholars, and junior faculty. The overall TOXI program is
organized around the theme of “Toxicological Predictions, Markers, and Outcomes Affecting Human Health”
and complements the National Meeting theme of Harnessing the Power of Data. The program includes
five thematic symposia, which will feature invited oral presentations by a diverse group of established and
emerging investigators with a range of perspectives on each topic. The five thematic symposia are: (1)
“Application of Augmented Artificial Intelligence in Toxicology Metabolism Prediction”, co-promoted by the
Divisions of Chemical Information (CINF) and Medicinal Chemistry (MEDI), will explore the role of
augmented AI in predicting toxic metabolites; (2) “Toxicity & Drug-Drug Interactions Resulting from Inhibition
of Transporters”, co-promoted with MEDI, will examine the impact of inhibiting transporters to regulate drug
efficacies; (3) “Advanced in vitro Models for Chemical Toxicity,” co-promoted with MEDI, focuses on recent
progress in development of organ-on-chip systems on testing chemical toxicity; (4) “Linking Toxicology and
Human Health Through the Exposome”, copromoted with the Divisions of Biological Chemistry (BIOL) and
Environmental Chemistry (ENVR), describes recent advances in measuring lifetime of chemical exposures
and disparities in vulnerable populations; and (5) “Endogenous Metabolites in Aging and Disease”,
copromoted with BIOL, focuses on the chemistry and biology that underly cellular responses to
misregulated formation of endogenous metabolites. The scientific program is clearly aligned with the
mission of NIEHS.

Public health relevance
Narrative The mission of the American Chemical Society (ACS) Division of Chemical Toxicology (TOXI) is to improve human health and public welfare by promoting the understanding of chemical mechanisms that govern disease processes and the toxicity of environmental agents, drugs, and endogenous chemicals. The goal of this application is to support the TOXI scientific program at the ACS National Meeting, including sessions that focus on mechanisms and predictions by which environmental agents or metabolites cause toxicity. The conference is an opportunity to disseminate recent results and promote collaboration among environmental health scientists and chemists working in other specialty areas; therefore, this conference program is aligned with the health mission of NIEHS and NIH.